Development of soluble epoxide hydrolase inhibitors for the treatment of Alzheimer's disease

Abstract
Alzheimer’s disease affects 6 million Americans, is the 6th leading cause of death in the nation and substantially
impacts patients’ quality of life with no effective cure available. As the population over the age of 65 is projected
to triple by 2035, the number of Alzheimer’s disease patients is expected to increase by at least two-fold.
Therefore, there is an unmet medical need to develop novel treatments to prevent and or cure Alzheimer’s
disease.
Recent studies indicate that soluble epoxide hydrolase (sEH) is a novel therapeutic target for Alzheimer’s
disease. Although the newer sEH inhibitors have sub-nanomolar potency, they generally suffer from poor blood-
brain barrier penetration and unsuitable physical properties. As a high percentage of sEH inhibition / engagement
is needed to elicit significant biological activity, sEH inhibitors with high blood-brain barrier penetration and
exposure are needed.
Although the structure-activity relationships (SARs) of sEH inhibitors have been extensively investigated, their
impact on blood-brain barrier penetration has rarely been studied and the existing clinical candidates are
predicted to have poor CNS exposure. While most of the SAR studies focus on the substituents on both ends of
the inhibitors, the linker of the inhibitors has rarely been explored. We will investigate how modifications of sEHI’s
linker and other modifications affect its CNS drug-like properties and CNS exposure. We will then systematically
incorporate the optimized modifications to further improve sEHI’s drug-like properties and CNS exposure. Aim 1
of this project will apply a novel design-test-learn strategy to guide the design of the novel sEHIs using our in-
house assays to screen sEHIs potency, binding kinetics and in vitro pharmacokinetic parameters. The top
candidates will be screened for their PK properties and CNS exposure using our established low dose oral
cassette dosing methodology. We will then further determine the detailed pharmacokinetic properties and CNS
exposure parameters of the selected candidates. As the program progresses, we will our observations for further
optimization. The optimized candidates will be selected based on the new sEHIs’ potency, binding kinetics, CNS
drug-like properties, pharmacokinetic parameters and CNS target engagement for the in vivo efficacy testing. In
Aim 2, the optimized sEHIs will be subjected to a 7-day dose range finding experiment and the sEHI, which can
inhibit at least 90% of brain sEH with the lowest dose, will be selected for testing in mouse and rat Alzheimer’s
disease models to determine their efficacy.

Public health relevance
Project Narrative Alzheimer’s disease is the sixth leading cause of death in the United States with no effective treatment, and the number of patients will triple by 2050. Inhibition of an enzyme called soluble epoxide hydrolase (sEH), which hydrolyzes endogenous largely beneficial epoxy fatty acid to proinflammatory dihydroxy fatty acid, alleviates Alzheimer’s pathological hallmarks and symptoms, like neuroinflammation, tauopathy, amyloidosis and, cognitive dysfunctions suggesting that sEH inhibitor is a rational therapeutic target. This project aims to develop a novel sEH inhibitor with high potency, significantly improved CNS drug-like properties, and CNS exposure to treat Alzheimer’s disease.